SEER Related Vital Status

The Social Security Administration (SSA) will use information on individual study subjects submitted by the National Cancer Institute (NCI) to search SSA databases to determine whether each person reported to SSA as deceased, is presumed living, or there is not sufficient information to make a determination of vital status. NCI will use the information for research on cancer survival statistics. NCI will provide information to cancer registries participating in the Surveillance Epidemiology and End Results (SEER) Program. The cancer registries are NCI contractors. The purpose of this modification is to increase the number of NCI cancer registries participating in the SEER Program from 18 to 28 and to make minor corrections to three of the currently listed NCI cancer registries.